A map of ribosomal RNA regulation in human hematopoiesis

Project Summary / Abstract
The hematopoietic tree contains cells of varying sizes, functions, and proliferation kinetics, and each cell type
has a tightly regulated number of ribosomes. Ribosomal RNA (rRNA) forms the majority of ribosome mass,
and is the most abundant cellular RNA, but rRNA/rDNA are often ignored in high-throughput studies due to a
lack of suitable bioinformatic tools. In this proposal, we ask fundamental questions about rRNA regulation in
human hematopoiesis by re-mapping existing datasets to custom genome assemblies generated by our lab.
rDNA alleles are present in 200-600 repeat copies, and a subset is transcribed by Pol I into nascent rRNA.
Transcription of rRNA is the rate-limiting step of ribosome biogenesis, and shows >10-fold variation across
hematopoietic cell types. The mechanisms controlling this variation are understudied, and even though every
high-throughput library contains rRNA/rDNA reads, standard mapping algorithms discard these reads.
We recently generated custom genomes for rDNA mapping by masking rDNA fragments from human/mouse
assemblies and adding a single ~45-kb reference rDNA sequence as a new “chromosome R”. We used this
approach to map an atlas of hematopoietic transcription factor (TF)-rDNA binding encompassing ~2200
ChIP-Seq tracks for ~250 factors. We identified that the myeloid TF CEBPA binds rDNA and promotes rRNA
transcription. Our overarching model is that rRNA is regulated across hematopoiesis through a combination of
differential rDNA repeat activation and regulation by lineage-specific TFs. We will interrogate this model
through novel analyses of existing and publicly-available human datasets.
Specific Aim 1: We will quantify dynamics of rDNA copy activation in human hematopoiesis as follows: (A)
Since inactive rDNA copies are heavily methylated, we will map whole genome bisulfite sequencing datasets to
our custom genome to quantify rDNA methylation dynamics in the trajectory from HSCs to myeloid cells. (B)
Since active rDNA copies show broad MNase-accessibility, we will use ATAC-Seq datasets to quantify changes
in rDNA accessibility from HSCs to myeloid cells. Impact: Determining whether rDNA repeats are differentially
activated at key transitions will guide studies on whether modulating rDNA methylation affects cell fate.
Specific Aim 2: We will identify regulators of rRNA levels in human HSPCs as follows: (A) We will map HSPC
single-cell (sc) RNA-Seq datasets to our custom genome to quantify 18S, 28S levels in addition to the broader
transcriptome. We will assess whether rDNA-binding TFs, chromatin factors, or signatures of HSC quiescence
correlate with rRNA levels. (B) We will map data from a Perturb-Seq study that combined CRISPR-interference
screen with scRNA-Seq in K562 cells to profile mRNA effects of perturbations in ~10K genes. We will map this
dataset to identify factors whose repression alters 18S, 28S levels. Impact: These studies will establish a
single cell ribosome abundance map in hematopoiesis, identify TFs and other factors that control ribosome
subunit levels, and prioritize novel candidates for study in normal and disordered hematopoiesis.

Public health relevance
Project Narrative Ribosomes are nanomachines responsible for all protein production within the cell, and different cell types contain different numbers of ribosomes. It is largely unknown how ribosome numbers are controlled in the cell types that make up the human blood system. We will re-analyze existing datasets to extract hidden information about ribosome production and numbers in human bone marrow, with the goal of gaining insight into the control of ribosome production in health and disease, and generating better therapies for marrow disorders.